Identification of Novel Regulatory Mechanisms Driving Human beta-Cell Maturation and Function.

Abstract
Type 1 Diabetes mellitus (T1D) is an autoimmune disease targeting pancreatic β-cells that affects over 8 million
people worldwide. Standard treatment for T1D is limited to administration of exogenous insulin, which can result
in hypoglycemic episodes, and fails to fully prevent micro- and macro- vascular complications. Thus, deriving
glucose-responsive insulin-producing β-cells from renewable sources is an index goal of regenerative medicine.
Yet, current human stem cell-derived β-cells produce insulin at lower levels than native β-cells and fail to
recapitulate regulated insulin secretion typical of mature adult islet β-cells. This limits their therapeutic potential
and reflects a significant gap in our knowledge regarding mechanisms regulating human islet maturation. Exciting
recent studies identified human-specific age-dependent gene expression changes, including novel transcription
factors, such as RXRG, not expressed in mouse or immature human β-like cells, that might control functional
maturation of human islet cells. My Preliminary Data shows that RXRG loss in human adult β-cells results in
impaired glucose-stimulated insulin secretion. Recent studies also showed that gradual turnover of enhancers
drives lineage progression and maturation. I have found a presumptive enhancer regulatory element of RXRG
that becomes differentially accessible with age in adult β-cells compared to immature β-cells and a-cells, as
measured by H3K27Ac occupancy. My objective here is to discover mechanisms that induce maturation of
human β-cells, using two approaches. In Aim 1, I will investigate the regulatory roles of the novel
transcriptional regulator of β-cell maturation RXRG. This will involve knock down of RXRG, and then β-cell
specific RNA-seq and CUT&RUN to identify RXRG downstream targets. In addition, I will activate RXRG
endogenous promoter using the CRISPRa system and evaluate chromatin accessibility changes induced by
activation of this maturation-required transcription factor. In Aim 2, I will study the non-coding regulatory
mechanisms activating RXRG expression to induce β-cell maturation. Since these mechanisms do not occur
in mouse or stem cell-derived human β-cells, and are specific to adult β-cells, the studies I proposed will be
performed in adult human islets using the pseudoislet-genetics platform I developed during my postdoctoral
studies. Here, I will use novel technological advancements, including CRISPR-Cas9 ribonucleoprotein (RNP)
editing of human islet cells, to delete the presumptive enhancer element of RXRG and evaluate its role in
regulating RXRG expression. Finally, I will activate RXRG expression in juvenile islets using CRISPRa to activate
RXRG promoter, enhancer or both, and evaluate if RXRG expression enhances coordinated glucose-dependent
insulin secretion in adulthood. Altogether, findings from this proposal will uncover novel pathways leading to β-
cell maturation, that could be exploited towards efforts with β-cells from renewable sources. Equally importantly,
these studies provide a novel toolkit for genetically manipulating previously “unstudiable” or inaccessible non-
replicating mature and immature β-cells.

Public health relevance
Project Narrative Type 1 Diabetes (T1D) affects 8.7 million people globally and 1.6 million in the US, and as many as 4-5 million Americans are at risk of developing T1D. T1D results in destruction of beta cells and loss of insulin, prompting an urgent need for regeneration and replacement of fully mature, functional beta cells. Here, I am developing unique genetic tools to elucidate the final crucial steps in human beta cell differentiation, understanding that will allow both generation of fully functional replacement human beta cells, and also identification of druggable targets for beta cell regeneration, highly required for treatment of people with T1D.